Hepatic stellate cells in NASH fibrosis and HCC

Non-alcoholic steatohepatitis (NASH) is a rising public health threat characterized by progression from steatosis,
to hepatocyte injury, inflammation, fibrosis and hepatocellular carcinoma (HCC). A key unanswered question is
how inflammation and hepatic fibrosis create a ‘pro-carcinogenic stroma’ that promotes the development of
hepatocellular carcinoma (HCC), even without co-existent cirrhosis. Central to these stromal changes is the
activation of hepatic stellate cells (HSCs), which are resident perisinusoidal, vitamin A-rich cells that
transdifferentiate into myofibroblasts (cancer-associated fibroblasts, or CAFs) to secrete a host of extracellular
matrix constituents, growth factors, and cytokines. The objective of this research is to clarify the role of hepatic
stellate cells in the pathogenesis of NASH and HCC. We and our collaborators have developed two highly
efficient, complementary models of HSC depletion that can address critical gaps in understanding their role in
NASH fibrosis and HCC: 1) JEDI (“Just EGFP death inducing”) T-cells, in which CD8+ T cells engineered to kill
cells that express green fluorescent protein (GFP) are administered to transgenic mice, in which GFP is driven
by the b-PDGF receptor promoter, killing 99% of HSCs; 2) CAR T cells targeting urokinase plasminogen
activated receptor (uPAR), which eliminate only senescent HSCs in murine liver. Concurrently, we have created
a highly reproducible murine NASH model that faithfully replicates the histology, fibrosis progression and HCCs
of human NASH. Our central hypothesis is that activated and senescent HSCs in NASH express unique drivers
that contribute to a tumor-prone stromal microenvironment. Thus, this proposal concurrently investigates the
dynamics and unique contributions of HSCs to NASH, and the stromal abnormalities they generate that give rise
to HCC. We will address this hypothesis in three interrelated, but distinct Specific Aims:1) To define the
dynamics, origin and cellular features of HSC repopulation before and after their depletion in normal and NASH
mice; 2) To establish the relative contributions of senescent and non-senescent HSCs to NASH fibrosis and
HCC; 3) To identify HSC-derived stromal drivers of HCC in murine and human NASH. This innovative approach
leveraging unique animal models is significant because it will yield fundamental new insights into HSC biology
in health and disease, define specific stromal drivers that they regulate, and link abnormalities from mouse
models to human NASH-HCC to establish their clinical relevance as potential therapeutic targets.

Public health relevance
Chronic non-alcoholic steatohepatitis (NASH) of the liver is a public health priority because it leads to scarring, or fibrosis, and is the fastest rising cause of primary liver cancer development, affecting millions of individuals worldwide. We propose to clarify the behavior of fibrogenic cells known as hepatic stellate cells that generate scar in this disease, and characterize how they contribute to primary liver cancer. New insights expected to emerge from these studies could significantly advance our understanding of how to prevent and treat liver fibrosis and cancer in patients with NASH, thereby improving the lives of patients with liver disease, which is highly relevant to the NIDDK mission, throughout the developed and developing world.